Project 3: Role Played by ASIC, P2X and EP4 Receptors in the Exercise Pressor Reflex in Health and Simulated PAD

PROJECT SUMMARY/ABSTRACT – PROJECT 3 A reflex arising from the contraction of hindlimb skeletal muscles is an important neural mechanism that is responsible for the cardiovascular adjustments to exercise. These adjustments, which include increases in peripheral vascular resistance, cardiac contractility and rate, function to increase arterial blood flow and oxygen supply to the exercising muscles, and in turn support their ability to contract. This neural mechanism has been named the exercise pressor reflex and its afferent arm is comprised of group III and IV fibers whose endings are located in and near the muscle interstitium. In patients with peripheral artery disease (PAD) the exercise pressor reflex is exaggerated. The overall goal of the experiments proposed in this unit is to shed light on the metabolic factors occurring in contracting muscles that are responsible for evoking this PAD-induced exaggeration of the reflex. Metabolic factors produced by contracting skeletal muscles are believed to signal the spinal cord and brain that the arterial blood supply to working muscle does not meet its metabolic demand. These metabolites are therefore prime candidates for stimulating the group III and IV afferents responsible for evoking the exaggerated exercise pressor reflex in PAD. In the proposed experiments, we will pay particular attention to three important metabolic by-products of contraction, namely Lactic Acid, which stimulates the ASIC3 channel, Prostaglandin E2, which stimulates the endoperoxide (EP)4 receptor, and ATP which stimulates the P2X3 receptor. We will examine in decerebrated unanesthetized rats the responses to contraction of group III and IV muscle afferents both before and during either pharmacological blockade of the above receptors or after they have been “knocked down” with siRNA. The proposed experiments will also examine the responses to contraction of these thin fiber afferents before and during knockdown of myophosphorylase in the triceps surae muscles. The proposed experiments will be performed both in rats with freely perfused femoral arteries and in rats with femoral arteries that have been ligated for 72 hours before the start of the experiment. The latter preparation simulates the arterial blood flow patterns seen in patients with PAD and therefore serves as a useful animal model of this disease. The proposed experiments are anticipated to provide new information about metabolic factors that cause the exercise pressor reflex to be exaggerated in PAD.

Public health relevance
PROJECT NARRATIVE – PROJECT 3 Exercise is well known to stimulate thin fiber sensory nerves in contracting muscles. Stimulation of these nerves reflexively activates the sympathetic nervous system, an effect which causes vasoconstriction in the heart, kidneys and the skeletal muscles. In hearts whose coronary arteries are narrowed by disease, this vasoconstriction can cause chest pain and fatal arrhythmias. Likewise, in muscles, whose arteries are narrowed by disease, this vasoconstriction can cause muscle ischemia and result in pain that is only relieved by the cessation of exercise (i.e., intermittent claudication).